A Longitudinal Mixed-Methods Investigation of Masculinity, Stigma, and Disclosure on Men's ART Initiation in South Africa

Project Summary
South Africa is home to over 7.9 million people living with HIV, the largest of any country globally. One
significant barrier to ending the HIV epidemic is engaging and retaining men in care throughout the HIV care
continuum. At each step, men are less likely than women to be engaged in care. Hegemonic masculinity, or
idealized forms of what it means to ‘be a man,’ is documented as a major reason why men do not seek and
stay engaged in care. Hegemonic masculinity in South Africa involves risk-taking, self-reliance, being sexually
desirable, physical strength and health, having emotional control, and being an economic provider. Although
these traits may be protective for men under certain circumstances, they are also inconsistent with seeking HIV
care, which requires vulnerability, experiencing emotions traditionally viewed as more feminine (e.g., sadness),
and invoking a relational dimension (as opposed to self-reliance). Further, the extent to which men internalize
hegemonic masculinity, called hegemonic masculinity beliefs (HMBs), makes disclosure of their HIV status
challenging for the same reasons; yet, disclosure is often the avenue through which men gain the necessary
social support needed to seek and be retained in HIV treatment. In this mixed-methods study, we use
Connell’s definition of hegemonic masculinity and the Disclosure Process Model to examine modifiable
mechanisms that link HMBs to antiretroviral therapy (ART) initiation in newly-diagnosed men living with HIV
(MLWH) in Cape Town, South Africa. We propose to do the following: (1) Examine whether disclosure
mediates the association between HMBs and ART initiation, such that stronger HMBs will be associated with a
decreased likelihood of HIV disclosure, which in turn will be associated with a decreased likelihood of ART
initiation. We will also examine whether internalized stigma moderates the association between HMBs and
disclosure, such that the negative association between HMBs and disclosure will be stronger in the context of
high internalized stigma. We will recruit newly-diagnosed MLWH (N = 220) and assess HMBs within two weeks
of testing positive and then again 3 and 6 months later. Data on ART initiation will be assessed at the 6-month
assessment via chart review. (2) Examine whether, and how, the process of disclosure shifts men’s views of
their own masculinity. We predict that men who disclose their HIV status during the study will experience a
decrease in HMBs at the 6-month assessment, because theoretically disclosure as a behavior is inconsistent
with HMBs. A subset of men who disclose their HIV status (n = 10) and those who do not disclose (n = 10) will
be randomly selected to participate in a qualitative individual interview to further explain if, and how, disclosure
led to a shift in HMBs. This proposed study is in line with the NIH Office of AIDS Research’s cross-cutting
research priority on behavioral sciences focused on individual and interpersonal dynamics that influence HIV
care. Results will be used for subsequent intervention development.

Public health relevance
Project Narrative Engaging and retaining men in HIV care is critical to the success of ending the HIV epidemic, particularly in South Africa where over 7.9 million people live with HIV. Idealized forms of masculinity may impede men’s antiretroviral therapy (ART) initiation through non-disclosure of HIV status. This study will test whether men who hold unhelpful idealized beliefs about masculinity have more difficulty disclosing their HIV status, and in turn, are less likely to begin ART, the life-saving medications that reduce HIV transmission rates and keep people with HIV healthy.